Enhancing Addiction Severity Prediction by Modulating GABAergic Activity in the Central Amygdala of RATTACA Rats

Project Summary/Abstract
Cocaine Use Disorder (CUD) represents a significant public health challenge, characterized by a complex
interplay of genetic, environmental, and individual factors, and limited treatment options. Despite advances in
understanding the genetic underpinnings of addiction vulnerability, a critical gap remains in elucidating the
neurobiological mechanisms underlying addiction susceptibility, particularly regarding pre-existing cellular
differences. The present study aims to investigate pre-existing differences in GABAergic and glutamatergic
transmission within the central amygdala (CeA) and their potential contribution to individual differences in
addiction susceptibility. We employ a novel method called RATTACA, which leverages extensive genotype and
phenotype data to enable polygenic trait prediction in naïve rats, allowing for the selection of animals with
predicted high and low cocaine addiction-like behaviors before exposure to cocaine. Specific Aim 1 focuses on
characterizing and comparing basal GABAergic and glutamatergic transmission in the CeA of rats with high and
low predicted susceptibility to CUD. Specific Aim 2 examines the hypothesis that cocaine differentially
modulates GABAergic and glutamatergic transmission in the CeA of rats with high and low predicted
susceptibility to CUD by applying cocaine ex vivo and performing electrophysiological recordings. Preliminary
data demonstrate that animals with a predicted high cocaine addiction-like behavior phenotype exhibit a higher
level of tonic GABA release compared to animals predicted to have low cocaine addiction-like behaviors, with
cocaine reducing GABA release only in the predicted high rats. These findings underscore the potential of our
approach to investigate pre-existing individual differences at the cellular level, which may contribute to the
observed individual differences in addiction-like behaviors. This study will provide insights into the role of
GABAergic and glutamatergic transmission in the CeA in addiction vulnerability and inform potential therapeutic
targets for CUD and other substance use disorders.

Public health relevance
Narrative This study investigates the neurobiological mechanisms underlying addiction vulnerability by examining pre- existing differences in GABAergic and glutamatergic transmission within the central amygdala (CeA) of rats with high and low predicted susceptibility to Cocaine Use Disorder (CUD). By utilizing the novel RATTACA method, we can select animals before exposure to cocaine, enabling the assessment of pre-existing cellular differences. Our aims involve characterizing basal neurotransmission, comparing the differential effects of cocaine on GABAergic and glutamatergic transmission in the CeA, and ultimately providing valuable insights into addiction vulnerability that may inform potential therapeutic targets for CUD and other substance use disorders.